MAOA and AR Reciprocal Crosstalk in Prostate Cancer

Project Summary/Abstract
Prostate cancer (PC) is the most common non-skin cancer in American men, with a lifetime incidence of 1 in 7,
and also the second leading cause of cancer death in American men. Androgen receptor (AR) is the primary
oncogenic driver of PC growth, survival and progression. AR-directed therapy is currently the principal
treatment regimen. Despite initial response rates exceeding 90%, PC eventually relapses and progresses to
fatal castration-resistant PC (CRPC), where reactivation of AR signaling occurs in a low-androgen environment.
Recent introduction of FDA-approved next-generation antiandrogens, including enzalutamide (ENZ) and
abiraterone acetate (ABI), have improved the CRPC treatment landscape, but emergence of drug resistance
remains nearly universal, with no AR-targeted therapeutic options afterwards. These dismal facts underscore
the pressing clinical need to identify new molecular targets and develop effective therapies to combat
advanced PC. Through integrated analysis of publicly available clinical PC data sets coupled with functional
studies in AR-positive PC cells, we propose monoamine oxidase A (MAOA), which synergizes with AR to
promote PC, as an ideal therapeutic candidate to complement AR-targeted therapy in CRPC. We identified a
novel reciprocal interaction between MAOA and AR in PC cells. MAOA expression is induced by androgen
treatment; and conversely, MAOA silencing significantly reduces AR activity by lowering AR target gene
expression and responsiveness to androgen stimulation in PC cells under both androgen-replete and depleted
conditions as well as in a CRPC xenograft model. We showed significant positive co-expression of MAOA and
AR target genes (PSA, TMPRSS2, NKX3.1) in multiple clinical data sets, including CRPC. Importantly, we
found MAOA genomic amplification and/or epigenetic activation in 64% of samples in a CRPC data set,
reinforced by elevated MAOA protein expression in our CRPC patient cohort. Additionally, we demonstrated
that inhibition of MAOA by genetic or pharmacological approaches enhanced the growth-inhibiting effects of
ENZ and ABI in androgen-sensitive, CR and antiandrogen-resistant PC cells. Based on these findings, we will
test the hypothesis that MAOA synergizes with AR through reciprocal crosstalk and convergent downstream
signaling to amply MAOA/AR effects promoting AR-driven PC growth and progression, and that co-targeting
MAOA/AR is an actionable, effective strategy to treat CRPC and reverse antiandrogen drug resistance. To
address this hypothesis, three aims are proposed. In Aim 1, we will elucidate the mechanistic basis of MAOA-
AR reciprocal interaction in PC cells. In Aim 2, we will characterize the role of MAOA in regulating the
development and progression of CRPC in xenograft models. In Aim 3, we will determine the efficacy of MAOA
inhibitors for treating CRPC and reversing resistance to next-generation antiandrogens in vitro and in vivo.
These studies will provide fundamental innovative insights into AR regulation in CRPC and illuminate a path
toward the development of new combination therapy for advanced PC.

Public health relevance
Project Narrative Advanced prostate cancer patients often fail androgen receptor-directed therapy and develop lethal castration- resistant disease, which constitutes a major challenge in clinical management, raising an urgent need to develop effective new therapeutic strategies to improve patient survival. The proposed studies define the functional and mechanistic roles of monoamine oxidase A, a recently identified therapeutic target in prostate cancer, which synergizes with androgen receptor to form a reciprocally interactive complex promoting prostate cancer growth and progression. Our studies will provide new fundamental knowledge of the molecular basis of androgen receptor regulation and the development of resistance to castration and next-generation antiandrogen drugs, thus laying the foundations for a new combination therapy with the potential for rapid translation to treat advanced prostate cancers.